Microdata for Research on Aging in the Global South

Project Summary/Abstract
Over the past two decades, the Integrated Public Use Microdata Series (IPUMS) has created a vast database
of microdata covering most of the globe from the 1960s to the present. These data include detailed information
about each person's geographic location, demographic characteristics, and economic activities as well as
information on mortality, migration, disabilities, living arrangements, and housing features. IPUMS is currently
disseminating integrated data on approximately one billion persons drawn from 355 censuses of 89 countries,
including 212 censuses of 60 countries in the Global South. The data are interoperable across time and space,
enabling comparative analysis and the study of processes of change.
This proposal seeks funding to expand the scope of the IPUMS database and create powerful new tools for
analyzing population aging. The project has four major goals: (1) Expand the database, adding 40 censuses and
approximately 100 million cases for countries in the Global South; (2) Develop new individual-level variables on
disability, mortality, retirement, types of group quarters, familial living arrangements, migration, and economic
well-being indicators; (3) Develop new contextual variables describing environmental and socioeconomic
characteristics of approximately 15,000 places at the second administrative level in the Global South; and (4)
Provide user support, training, and outreach to population aging researchers to ensure that the data are broadly
accessible and widely used.
Leveraging billions of dollars of investments in census data, this project is a highly cost-effective use of scarce
resources to develop shared big data infrastructure for research, education, and policy-making on population
aging. The proposed database directly addresses core goals of the Population and Social Processes Branch of
NIA by providing a resource of unprecedented power for understanding the effects of public policies, social
institutions, and environmental conditions on the health, well-being, and functioning of people over the life course
and in their later years across the developing world.

Public health relevance
Project Narrative A core mission of the Population and Social Processes Branch of NIA is developing infrastructure for international and comparative research to further our understanding of how different social, familial, environmental, geographic, cultural and institutional contexts influence the aging process. The proposed database directly addresses these goals by providing a resource of unprecedented power for understanding the effects of public policies, social institutions, and environmental conditions on the health, well-being, and functioning of people over the life course and in their later years across the developing world.